Periodontitis Role in Inflammatory Bowel Disease

PROJECT SUMMARY/ABSTRACT
As opposite ends of the orodigestive tract, the oral cavity and the intestine share anatomic,
microbial, and immunologic ties that have bidirectional health implications. Our group has been
at the forefront of unravelling the impact of oral health on intestinal health. Our recent clinical
study highlighted a significant association between periodontitis, a prevalent oral infection, and
inflammatory bowel disease (IBD), a chronic gastrointestinal disorder. IBD patients suffer from
diarrhea, rectal bleeding, abdominal pain, and have a diminished quality of life, and shorter life
expectancy. Between 1990 and 2017, the global incidence of IBD has surged by 31%, becoming
a global health concern. To date, the etiology of IBD remains unclear, hindering the development
of effective cures. The objective of this proposal is to elucidate the potential causal role of
periodontitis in IBD using mechanistic studies in pre-clinical models, that serve as key
investigative tools. Our preliminary data indicate that the concurrent presence of impaired
intestinal barrier function and periodontitis increase the risk for intestinal inflammation. Based on
this, our central hypothesis posits that in hosts with impaired intestinal barrier function,
concurrent periodontitis enables certain oral pathogens to colonize the intestine and induce
colonic inflammation. Our hypothesis will be tested using three Specific Aims that leverage
animal models with intestinal barrier function disrupted by either genetic deficiency or
medications. In Aim 1, we will determine if oral bacteria from IBD patients and ligature-induced
periodontitis mice colonize the intestines to promote colonic inflammation. In Aim 2, we will
elucidate the aberrant inflammatory responses activated by periodontitis and oral pathogens that
mediate colonic inflammation. In Aim 3, we will identify the gastric acid resistance mechanisms of
oral bacteria that enable them to overcome stomach acidity and colonize the gut, promoting
colonic inflammation. Our rationale is that identification of pathways by which oral pathogens
induce colonic inflammation will help in developing transformative oral-centric IBD therapies. The
proposed research is significant because it will spur strategies to monitor oral health, optimize
dental care, and target immune perturbations to reduce IBD risk in susceptible individuals.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: Inflammatory Bowel Disease (IBD) affects over 6.8 million people worldwide with no existing cure, and its primary causes remain uncertain. Mounting evidence suggests that periodontitis, a prevalent oral infection, may contribute to the development and progression of IBD. The proposed research is of public health relevance as it will provide transformative knowledge about the role of periodontitis in IBD utilizing pre-clinical mouse models, which will help in developing novel clinical therapies for IBD.